Molecular mechanisms controlling stress responses and cell adhesion in bacteria

Project Summary/Abstract
We seek to understand molecular mechanisms that enable bacteria to survive in complex, dynamic
environments, including mammalian hosts. The research program proposed here will build on advances made
by our team in the previous term of this award, which have centered on two themes: 1) signaling mechanisms
that support cell survival during stress, 2) regulatory mechanisms that mediate bacterial cell interactions with
abiotic surfaces and with bacteriophage. Over the next five years, we will utilize an interdisciplinary set of
genetic, biochemical, and structural approaches to study these processes on multiple scales, from the systems
level to the level of molecular structure. The data that emerge from our studies will enhance understanding of
processes that allow bacteria to grow and survive in complex environments and will inform new concepts in
gene regulation and cell envelope biology. More specifically, this project will provide the scientific community
with an integrative understanding of sensory transduction mechanisms in bacteria and will lead to improved
understanding of the molecular mechanisms underlying biogenesis of the complex structure known as the
envelope, which separates the tightly controlled activities in the cytoplasm from the outside world. In this next
period of the award, we further propose to extend our studies to include mechanisms by which XRE family
transcription factors – which are known regulators of envelope polysaccharide biosynthesis - influence host-
phage dynamics. Sensory transduction proteins and cell envelope polysaccharides are well-defined virulence
determinants in many bacterial pathogens. Thus, our work has the potential to inform new therapeutic routes to
control certain bacterial infections.

Public health relevance
Project Narrative Bacterial cell survival hinges on their ability to sense and adapt to various environmental signals. This project aims to dissect the molecular systems that govern bacterial stress responses, surface attachment (i.e. biofilm formation), and interactions with bacteriophages. The data that will emerge from this research has the potential to inform new methods to control bacterial growth and infection in clinical settings.